The Impact of Discontinuing Medications for Opioid Use Disorder After Surgery: Evaluating Predictors and Outcomes to Guide Perioperative Care

PROJECT SUMMARY / ABSTRACT
Medications for opioid use disorder (MOUD) decrease risk of relapse, overdose, and death in individuals with
opioid use disorder (OUD) and have been studied extensively in non-surgical patients. However, even once
patients initiate MOUD—which is meant to be used on a long-term or even lifelong basis—a large proportion
discontinue it, often following stressful or painful events. In surgical patients with OUD, there is still a critical
gap in understanding how exposure to acute pain via surgery affects postoperative MOUD discontinuation vs
treatment retention and sequelae including longer-term, comprehensive addiction-related, pain-related, and all-
cause outcomes. The central hypothesis for this study is that risk of postoperative MOUD discontinuation
varies by both fixed and modifiable clinical factors and that postoperative MOUD discontinuation is a risk factor
for OUD-related adverse events. The rationale for the proposed research program is that it is expected to
inform the development of interventions aimed at safely guiding patients with OUD through the perioperative
period while helping to establish my independence as a physician-scientist. The central hypothesis will be
tested through two specific aims: 1) Identify risk factors for discontinuation of MOUD after surgery and develop
a risk calculator to predict MOUD discontinuation, and 2) Estimate the association between postoperative
MOUD discontinuation and adverse outcomes in surgical patients. These aims will be achieved via a
retrospective cohort study and state-of-the-art statistical methods for causal inference in observational studies.
The proposed research is innovative because it will leverage three large, nationally representative claims
databases and apply sophisticated statistical methods to estimate postoperative MOUD discontinuation and its
association with longer-term adverse postoperative outcomes. The research project is significant because it is
expected to provide real-world, actionable guidance on the perioperative management of OUD, benefiting the
growing population of patients who live with OUD as a chronic condition and will require surgery in their
lifetimes. This work will be critically informative for future research led by the candidate on perioperative
practices that decrease risk of adverse postoperative events in patients with OUD. The proposed integrated
research and training will be accomplished at Stanford University with the support of an exceptional mentorship
team. The candidate will build on a solid background in anesthesiology, public health, and health services
research to gain relevant expertise in pain and addiction medicine, advanced statistical methods for health
services research, usage of Medicaid claims data, and scientific communication. Together, the research and
training will advance the candidate’s long-term goal to develop an independent research program as a
physician-scientist aimed at improving prevention and treatment of substance use disorders in patients with
acute or chronic pain. Ultimately, the continuum of research will have a positive impact by providing a strong
evidence base for targeted specialty care of the growing and vulnerable population of patients with OUD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will identify risks and modifiable risk factors in the growing population of surgical patients who use evidence-based medications for opioid use disorder. Given national efforts to increase utilization of medications for opioid use disorder, this research is timely and will provide a robust evidence base for targeted specialty care of those who live with opioid use disorder as a chronic condition and may require surgery during their lifetimes. The project is relevant to NIH’s mission because it aims to understand how to reduce morbidity and mortality in individuals who suffer from opioid use disorder, thereby enhancing their health, longevity, and quality of life.